Administrative Core

PROJECT SUMMARY
The Administrative Core will create and implement effective organizational processes and resources to support
the proposed Community-Driven Indigenous Research, Cultural Strengths & Leadership to Advance Equity in
Drug Use Outcomes (CIRCLE) Center. The core will provide an overarching structure for effective, interactive,
high-quality research, training, and practice activities that will support the public health and educational impacts
of the CIRCLE Research Center of Excellence. This includes enacting an organizational structure to maximize
collaboration for Indigenous and allied leadership; promoting synergies and collaborative opportunities among
CIRCLE Center affiliates and community partners; leading as a national resource via educational and scientific
resources available to the public, Indigenous, and scientific communities; supporting the next generation of drug
use researchers and scholars; using CIRCLE Center evaluation metrics to propel action and track progress; and
performing strategic planning to guide next steps and future work. The CIRCLE Center will be led by MPIs Dr.
Melissa Walls and Dr. Allison Barlow with significant guidance from a Tribal Community Leadership Council,
Internal Steering Committee, and External Advisory Board.